DHA brain delivery by APOE genotype

Carrying the APOE ɛ4 gene allele is the strongest genetic risk factor for developing Alzheimer's disease (AD). In contrast, APOE ɛ2 gene allele protects against AD. Consequently, identifying the mechanisms by which APOE alleles alter AD risk is very important to public health. The overall goal of this research is to identify the critical mechanisms that distinguish APOE ɛ2 from APOE ɛ4 in order to develop interventions that prevent or ameliorate AD risk by mimicking favorable differential effects of the APOE ɛ2 variant. The objective of this particular project is to test whether brain apoE lipidation differentiates APOE ɛ2 from APOE ɛ4 variant. We are interested in how ApoE HDL in the brain regulates the metabolism of the omega-3 (ω-3) polyunsaturated fatty acid docosahexaenoic acid (DHA). We recently demonstrated that in patients with mild AD, APOE ɛ2 carriers have greater cerebrospinal to plasma DHA ratio compared with APOE ɛ4 carriers. After 18 months of DHA supplementation, APOE ɛ4 carriers had less delivery of DHA to the brain compared with non-carriers. Using [11C]-DHA PET, we demonstrated that younger APOE4 carriers have a deficit in brain DHA compared with non-carriers. We hypothesize that reduced ApoE4 lipidation underlies the changes in DHA brain delivery in the context of APOE ɛ4 genotype. To test our hypothesis, we propose in Aim 1 mechanistic studies to identify DHA transport by ApoE HDL both in vivo and in vitro. Using the apoE mimetic peptide CS-6253, we will test whether enhancing the lipidation of apoE4 proteins would enhance the delivery of DHA to the brain in APOE4 mice. In Aim 2, we develop a novel PET imaging technique for assessing [18F]-DHA brain uptake. We assembled an outstanding group of scientists with expertise in neurochemistry, brain imaging and lipid metabolism to complete our study goals. Our project will identify apoE lipidation as a potential therapeutic target for interventions that prevent or ameliorate AD risk by mimicking favorable lipid carrying effects of the APOE ɛ2 variant.

Public health relevance
Carrying the APOE ɛ4 gene allele is the strongest genetic risk factor for developing Alzheimer's disease (AD). In contrast, APOE ɛ2 gene allele protects against AD. Consequently, identifying the mechanisms by which APOE alleles alter AD risk is very important to public health. The objective of this particular project is to test whether increased lipid carrying capacity of apoE proteins differentiates APOE ɛ2 from APOE ɛ4 variant. We plan to develop a novel PET imaging method to assess the effect of enhancing apoE lipid carrying capacity on the delivery of the omega-3 DHA to the brain.